Imaging the Effects of Intermittent Thetaburst Stimulation on Cannabis Self- Administration in Heavy Cannabis Users

PROJECT SUMMARY/ABSTRACT
The expanding legalization of cannabis across the U.S. is associated with increases in cannabis use, and
accordingly, an increase in the number of individuals with cannabis use disorder (CUD). One predictor of relapse
is an elevated attentional bias to drug cues and attenuated cognitive control in the presence of drug cues.
Attentional bias to drug cues is associated with elevated activity in the Salience Network (anterior cingulate
cortex and bilateral anterior insula), and attenuated activity in the dorsolateral prefrontal cortex (DLPFC) and
cognitive control circuitry when users are exposed to cannabis cues. Data from our laboratory demonstrates that
it is possible to decrease the neural response to drug cues by attenuating the VMPFC and reward circuitry
(Strategy 1) with inhibitory repetitive transcranial magnetic stimulation (rTMS). It is possible, however, that
elevating activity in the DLPFC and cognitive control circuitry will also decrease the neural response to drug cues
(Strategy 2 - topic of this K01). Through the research and training plan outlined in this K01 proposal, I seek to
evaluate the ability of DLPFC rTMS to attenuate Salience Network drug cue reactivity and reduce cannabis self-
administration. This will be achieved by applying intermittent theta burst stimulation (iTBS), a form of excitatory
rTMS, to the DLPFC in heavy cannabis users. GOAL: The primary objectives of this K01 research project
are to (1) determine if DLPFC iTBS decreases cannabis self-administration, both inpatient and outpatient
in the natural ecology, and (2) determine if iTBS-induced changes in cannabis self-administration are
related to changes in Salience Network drug cue reactivity. DESIGN: Sixty (60) non-treatment-seeking,
heavy (near daily) cannabis smokers will be randomized to receive 10 daily sessions of either active or sham
iTBS to the DLPFC. Participants will remain inpatient for 17 days. During the inpatient stay, cannabis self-
administration and fMRI data will be collected before and after the 10 iTBS sessions. Cannabis use in the natural
ecology will be measured outpatient for 2 weeks prior to admission (baseline) and for 2 weeks following discharge
using Ecological Momentary Assessment (EMA). Time to first use and amount of resumed cannabis use will be
measured using EMA and corroborated by 3 follow-up visits where TLFB and urine toxicology will capture
cannabis and other drug use. We will test the hypotheses that active iTBS treatment will reduce neural reactivity
to cannabis cues (Aim 2) and will reduce cannabis self-administration, both inpatient (Aim 1), and in the natural
ecology (Exploratory Aim). Through this 5-year proposal, I will acquire a critical dataset that is needed in the field
of brain stimulation for treatment development in CUD. Additionally, it will provide me with critical data for a
subsequent R01 application wherein I plan to extend this line of treatment development research. Furthermore,
this project will greatly facilitate the training in human behavioral pharmacology and clinical research design and
analysis that I seek for advancement into an independent, interdisciplinary clinical addiction neuroscientist.

Public health relevance
PROJECT NARRATIVE Attentional bias to drug cues is one of the primary causes of relapse in heavy cannabis users. Preliminary data suggests that transcranial magnetic stimulation (TMS) may be a novel, non-invasive tool to decrease attentional bias-related drug cue reactivity in cannabis users. Building on prior data, the primary goal of this mentored research scientist development proposal is to evaluate the feasibility and efficacy of TMS as a tool to decrease attention to drug cues and reduce cannabis use, which is likely to have a significant impact on the development of brain stimulation as an innovative treatment approach for individuals with cannabis use disorder.